Cancer Research Training & Education Coordination (CRTEC)

CANCER RESEARCH TRAINING & EDUCATION COORDINATION: ABSTRACT
Training the next generation of cancer researchers and health professionals has been a central mission of the
University of Arizona Cancer Center (UACC) since its founding in 1976. UACC’s Office of Cancer Research
Training & Education Coordination (CRTEC) is led by the Associate Director of CRTEC, Margaret Briehl, PhD,
and Assistant Director of Clinical Training and Education, Aaron Scott, MD. They are assisted by three full-time
staff members, including an Operations Manager, a Science Educator, and a Grant Writer. A CRTEC Council
comprised of 12 leaders of training and education programs provides oversight of CRTEC efforts. CRTEC’s
vision is to promote the development of the next generation of cancer researchers across a pipeline of learners
by engaging individuals from elementary to high-school (K-12) through junior to mid-career level faculty and
health professionals. This vision is realized through promotion of high-impact training that supports team
science approaches to prevent and cure cancer. Developing a diverse workforce of cancer researchers and
health professionals to serve UACC’s unique Catchment Area is a high priority for CRTEC. During the current
reporting period, UACC Members have led eight T32s, three R25s, and one U54 training grant that provide
cancer-focused research opportunities. The Center’s two newest training programs are funded through R25
awards with a focus on building the research skills of underrepresented minority (URM) trainees at the
undergraduate, post-baccalaureate, and graduate-level. During the current funding period, 178 mentors (165
UACC Members) have mentored 1,198 trainees through UACC-led and other institutional training programs.
Collectively, these programs engage trainees from high school through postdoctoral fellowships. Thirty-seven
percent of UACC trainees are URM. UACC trainees who have entered the workforce are contributing to the
cancer field through careers in academia, industry, government, publishing, and working as health
professionals caring for cancer patients. CRTEC’s concerted efforts are accomplished through three Specific
Aims: (1) coordinate and develop cancer-focused training and education activities across the continuum of
trainees, (2) facilitate and expand cancer-focused professional development activities, and (3) track and
evaluate the impact of UACC’s cancer research training and education activities. CRTEC efforts over the next
5 years are expected to lead to a substantially more integrated learning pipeline, particularly among URMs,
that promotes transdisciplinary, translational research and professional careers in the cancer field.